Optimizing an extended care intervention to promote weight loss maintenance

PROJECT SUMMARY / ABSTRACT
Although behavioral interventions for obesity achieve clinically meaningful weight loss, post-treatment weight
regain remains a pernicious challenge. Extended care interventions that include evidence-based behavioral
strategies can improve weight loss maintenance (WLM), but many of these strategies require significant effort
and resources that can hinder treatment adherence. Thus, strategies are needed that increase individuals'
capacity (i.e., resources, abilities, and readiness) to consistently engage in WLM behaviors while minimizing the
effort required of treatment. However, the most effective strategies for this are unknown. By leveraging the
multiphase optimization strategy framework and a factorial experimental design, this application proposes an
extended care optimization trial to efficiently test four “minimally disruptive” intervention components (i.e.,
effective treatments designed to enhance capacity with limited participant burden). Following an initial 6-month
weight loss phase, participants achieving 5% weight loss (N=272) will be randomized into a 12-month trial to
receive 0-4 of the intervention components in addition to a core, extended care program. The minimally disruptive
components include: 1) reduced food variety (i.e., limiting number of energy-dense dinners and snacks), 2)
home-based resistance training (i.e., low-dose prescriptions performed x2/week), 3) buddy training and support
(i.e., leveraging individuals from existing social networks to provide support), and 4) acceptance and commitment
therapy (ACT) workshops (i.e., condensed ACT skills training). These components have empirical support for
weight management but are distinct from conventional behavioral WLM recommendations. Further, all are
designed to enhance individuals' capacity with limited burden. The primary outcome is WLM between
randomization and month 12. An optimized intervention package will be assembled based on the combination
of minimally disruptive components most effective for WLM. In addition, hypothesized mediators of each
treatment component and participant characteristics moderating treatment response will be examined. This
project will lead to an optimized WLM intervention package that can be evaluated in a subsequent confirmatory
randomized controlled trial. This line of research can inform best practices for the provision of WLM interventions,
improve long-term outcomes for individuals, and strengthen the overall public health impact of available weight
management interventions for disease prevention and management.

Public health relevance
RELEVANCE Although extended care promotes better weight loss maintenance (WLM) following initial weight management programs, conventional WLM interventions require significant effort and may fail to adequately support individuals' capacity to continue weight management efforts. By leveraging the multiphase optimization strategy framework and a factorial experimental design, this project includes an optimization trial to test four extended care intervention components designed to be “minimally disruptive” (i.e., effective treatments designed to limit burden): 1) reduced food variety, 2) home-based resistance training, 3) buddy training and support, and 4) acceptance and commitment therapy workshops. The goal is to develop an optimized intervention package that maximizes WLM and improves the public health impact of behavioral weight management interventions.